Prenatal to Preschool: The Impact of the Pandemic on Mothers and children, with a focus on syndemic effects on Black families

SUMMARY/ABSTRACT

Stressors that significantly impact on the health and well-being of adults and children can be seen affecting many different systems including education, the economy, housing, and healthcare, widening known disparities. This is of particular importance for families with very young children considering the criticality of the peripartum period on early neurodevelopment. Recent findings suggest that early maternal symptomatology can have lasting, and negative effects on parent-child interactions, infant/child development, and mental health of both women and children. Overall, these findings take on further importance when contextualizing the disparate exposure of Black children and their families to the syndemic. Although there is increasing knowledge of the impact of environmental and neighborhood factors on child development beginning prenatally, mechanisms underpinning these transmissions are still being investigated. Identifying women disproportionately impacted by the syndemic during the peripartum period, provides an opportunity to understand the developing child’s environment, mother’s mental health, and parenting experience, with the long-term goal of improving infant/young child neurodevelopmental and mental health outcomes by ensuring appropriate, precise, personalized interventions. The proposed multi-methods project consists of three aims that will longitudinally examine child neurodevelopmental outcomes by early identification of racially/ethnically diverse mothers with mental health challenges. The first aim implements extensive screening of postpartum Black and non-Hispanic White (NHW) mothers using a battery of questionnaires and clinical psychiatric interviews to identify mothers currently experiencing distress and psychopathology, as well as determining resilience factors uncovering cross-cultural differences that may exist. Fathers/secondary caregivers will also complete similar questionnaires assessing levels of support. The second aim identifies maternal concern about their child’s development and mental health at two developmental time points (24 and 48-months) and assesses mother/child interactions on a series of dyadic tasks. The final aim consists of qualitative interviews with a sub-sample of Black women characterizing the impact of the syndemic on their mental health, parenting practices, perceptions of their child’s early development, and trust in the healthcare system. The overarching goal of this application is to deeply characterize the experiences of women and children impacted by the syndemic, filling the gap in the research by identifying specific maternal, environmental, and neighborhood factors and mechanisms that critically influence early child development and mental health and allowing for future intervention development.

Public health relevance
PUBLIC HEALTH RELEVANCE Identifying the effects of a significant stressor and underlying systemic conditions, defined together as a syndemic, on mothers and children is critically important, as impaired parenting impacts neonatal development and infant/early child mental health. This study aims to apply complementary methods to investigate maternal experiences of the syndemic, note differences between Black and non-Hispanic White (NHW) women’s experiences, identify other stressors that may impact women’s mental health, and talk with Black women about their experiences with the syndemic and neighborhood and environmental factors. We will observe early child development and parental interactions at ages 24 and 48 months, to identify how toddlers’/preschoolers’ environment and mothers’ mental health contribute to their development and well-being.